CONTROL OF YEAST PLASMID INHERITANCE AND GENE EXPRESSION

Artificial yeast plasmid cloning vectors are inherited nonrandomly at mitosis, with most copies going to the mother cell, and few to the bud; evidently, DNA (or chromatin) associates nonrandomly with higher-order nuclear structures. In contrast, copies of the natural yeast plasmid 2- micron circle are partitioned evenly; this requires two plasmid proteins, REPl and REP2, and a specific target sequence, STB. These proteins also regulate transcription from several plasmid promoters, but the cis-acting sites required for this are unknown. The purpose of this project is to determine how REP partitioning works, and whether it is mediated by the same DNA-protein interactions that regulate transcription. The experimental approaches will include general and site-specific mutagenesis of the 2-micron circle to obtain mutants in partitioning; deletion analysis of the STB site and the promoters affected by REP partitioning; construction of very large linear and circular plasmids containing one or more STB sites, to assess the "reach" of the partitioning effect of such sites; the selection of host mutations in REP partitioning, to identify specific interactions of the plasmid proteins with nuclear structures; and overproduction of the REP proteins (and deletion mutants of REP1) for in vitro examination of their DNA- binding properties. The potential significance of the results of these studies is that they may suggest ways in which subnuclear localization of DNA sequences in eukaryotic cells affects their expression, a problem of fundamental importance; and that they may also reveal how specific structural interactions impede the free movement of DNA through the nucleus, which has implications for the mechanism o production of chromosomal nondisjunction, an important cause of birth defects. Additionally, certain outcomes of the "large DNA stabilization" could allow construction of high-copy minichromosome vectors, a technological advance.